Adaptive olfactory threshold testing in the clinical assessment of anosmia

Project Summary
Smell disorders are highly impactful in daily life. Gas leaks and spoiled food are undetectable dangers.
Adequate nutrition is compromised as food become unpalatable without the core contribution smell plays in
flavor perception. Affected individuals also feel disconnected from the world and other people, contributing to
an increased incidence of depression. Smell disorders may also be early indicators of other serious health
problems such as rhinosinusitis, skull base tumors, cerebrospinal fluid leaks, or neurological diseases such as
Alzheimer's disease, Parkinson's disease or multiple sclerosis. Smell disorders are also much more common
than most people believe, with one major pre-COVID-19 study finding that over 12% Americans age 40 and
older had hyposmia (a reduced ability to smell) or anosmia (an inability to smell). However, despite substantial
prevalence and significant health impacts, smell disorders remain routinely underdiagnosed, in part because
routine olfactory screening is not a part of primary care. A major impediment to incorporating objective,
validated smell tests in routine healthcare is that the current options are too time consuming and/or expensive.
Thus, a new option is needed if smell testing is to be embraced by medical providers as a part of routine
screening, analogous to the ubiquitous Snellen eye chart and handheld audiometer used in many primary care
clinics. Roughly a third of US adults receive an annual physical or preventive care visit. Including smell tests in
such visits would result in over 75 million tests per year. When an olfactory disorder is diagnosed or suspected,
it typically results in referrals to specialists (e.g., neurology, otolaryngology) and in procedures such as
surgeries, imaging, and endoscopy that are billable to health insurance. Thus, we expect that a low cost, rapid
smell test would provide a substantial return on investment for healthcare systems. To address this unmet
need for a robust, rapid, inexpensive, cross-cultural test of olfactory function that can be administered in varied
settings, we designed the Adaptive Olfactory Measure of Threshold (ArOMa-T). The ArOMa-T includes multiple
concentrations of a single odorant spaced over several log units of concentration and encapsulated in peel-
and-burst labels on a foldable card. The card is paired with an adaptive algorithm, implemented via a website
or app, that guides the patient through a sequence of odorant concentrations where each is selected based on
prior responses. By skipping non-informative concentrations, this test rapidly determines the patient's odor
detection threshold. The ArOMa-T can be self-administered and produced inexpensively at scale. In this
proposal, we will pursue three Specific Aims to move the ArOMa-T towards commercialization: we will (1)
compare the performance of the ArOMa-T against other validated smell tests; (2) develop an accompanying
application for real-time processing of the adaptive algorithm; and (3) assess provider experience with the test
and app in a real world clinical setting. Together, these studies will establish the technical merit, feasibility and
commercial potential of the ArOMa-T.

Public health relevance
Narrative Smell disorders are prevalent, highly impactful on health and quality of life, often associated with other serious health conditions, and routinely undiagnosed. A major barrier to including routine olfactory screening in primary care is the the need for a quick, robust, inexpensive, and cross-cultural test of olfactory function. This proposal aims to establish whether the ArOMa-T can meet that need.